Leadership and Administration Core

PROJECT SUMMARY/ABSTRACT (LAC)
Led by Melissa Morrow, PhD and James Goodwin, MD, the UTMB OAIC Leadership and Administrative Core
(LAC) will continue to provide scientific leadership, administrative infrastructure, and financial and regulatory
oversight in support of the activities and growth of our Center. The LAC employs an established shared
leadership model that optimizes efficiency, productivity, team science, interdisciplinarity, and coherence to
advance our theme: Enhance functional independence in older adults with chronic disabling conditions
by reducing health disparities. The specific aims of the LAC are to: (1) Provide scientific leadership and
direction toward the overall goals of the UTMB OAIC; (2) Manage the UTMB OAIC program in compliance with
applicable policies; and (3) Increase the UTMB OAIC’s impact locally and nationally. To achieve Aim 1, the
LAC will proactively stimulate research through local and national collaborations, incorporating input from the
Internal Advisory Board (IAB), External Advisory Board (EAB), and REC Advisory Committee (RAC); seek out
and attract new investigators with an emphasis on supporting new investigators and research populations; and
coordinate the integration of OAIC Cores with other national resources, including the OAIC network, Resource
Center Coordinating Network, and Clinician-Scientists Transdisciplinary Aging Research Coordinating
Center. To achieve Aim 2, the LAC will ensure Core utilization, productivity, quality, and efficiency through
continuous improvement tracking and evaluation; optimize Center efforts by conducting essential
research/administrative meetings (e.g., with the Scientific Advisory Panel, EAB, and RAC); ensure timely
communication with the NIA and OAIC Coordinating Center; organize participation at the annual national OAIC
Investigators meeting; promote UTMB OAIC opportunities that support community outreach; and assure
compliance with all applicable research policies. To achieve Aim 3, the LAC will advance the OAIC theme by
collaborating with other institutional programs; spearhead new collaborations with other OAICs on multisite
studies in disabled and disadvantaged geriatric patients; strengthen partnerships with the UTMB Health
System to translate research into clinical practice; emphasize continued collaborations with the Texas RCMAR
and the OAIC Hispanic Aging Council; and increase relationships with regional institutions to support new
research, build infrastructure to increase representation in clinical trials, and mentor early-career faculty. The
active participation of LAC leaders and advisors in UTMB’s administrative processes has engendered a
profound institutional transformation that has significantly improved the collaborative opportunities for aging
research at UTMB. Throughout the next cycle, we will leverage OAIC funding, substantial institutional
contributions, and external collaborations to amplify our program’s impact and innovation both locally and
nationally.